Bone Imaging Core

PROJECT SUMMARY/ABSTRACT - CORE D
The COBRE Center for Musculoskeletal Disease Research (CMDR) at the University of Arkansas for Medical
Sciences (UAMS) focuses on identifying the cellular and molecular causes underlying diseases and conditions
that negatively impact the musculoskeletal system. Bone imaging and analytical technologies at the tissue and
cellular level will be required to accomplish the goals of each Phase 2 research project. To fulfill this need, we
will split the former Bone Histology and Imaging Core, established during Phase 1, into 2 independent but highly
integrated new cores: the Bone Imaging Core (Core D) and the Histology, Biomechanics, and Human Tissue
Core (Core C). Core D will operate as a centralized and shared core facility to assist Project Leaders and other
CMDR members with the musculoskeletal imaging needed for their research efforts. The core will provide state-
of-the-art imaging resources for quantitative characterization of tissue and cellular changes underlying the
pathogenesis of the musculoskeletal disorders being studied. Thus, Core D will be critical for Project Leaders
and the long-term success of the CMDR. This new core will consolidate existing and new equipment into a large,
modern research space within the Department of Physiology and Cell Biology and will be staffed by well-trained
technical personnel who will be supervised by the Core Director. Core D will pursue the following specific aims:
1) Establish the Bone Imaging Core; 2) Deliver state-of-the-art musculoskeletal imaging and introduce new
analytical technologies to generate, analyze, and interpret bone-imaging data; and 3) Provide training in bone
imaging and support educational activities. The success of Core D, together with the other CMDR cores, will
benefit the work proposed in all research projects (Projects 1, 2, and 3) and expand the repertoire of analytical
tools to meet the growing needs of CMDR members, as well as the other investigators at UAMS.